MWF Mycobacteria Antigens in Occupational Hypersensitivity Pneumonitis

Project summary Occupational hypersensitivity pneumonitis (HP) in machine workers has been associated with mycobacteria that frequently colonize modern water-based metalworking fluids (MWFs). HP is an immune-mediated lung disease caused by inhalation of microbial antigens and is relatively poorly studied in terms of its diagnosis, pathogenesis, and treatment. Overall goal of this study is to identify and characterize antigens associated with HP-inducing potential of MWF mycobacteria species M. immunogenum (MI) and M. chelonae (MC) and evaluate their potential for HP immunodiagnosis and exposure assessment. In previous funding cycles, we have isolated multiple strains (genotypes) of both the species with variable antigenic characteristics. We will test our hypothesis that antigen diversity in MWF mycobacteria strains prevalent in commercial MWF is responsible for differentially inducing the HP symptoms and underlying immune response, and that the responsible specific antigens could form the basis for more informative diagnosis and personal and environmental exposure assessment. The specific aims are to: (1). Identify key antigens in MI and MC strains based on their relative interaction with the host immune system in an optimized mouse model of HP; (2). Recombinant production of the identified key antigens by cloning and protein expression and generation of specific antibodies; (3). Investigate potential of the specific antigens for early personal exposure assessment and immunodiagnosis in symptomatic versus asymptomatic individuals; (4). Evaluate potential of the specific antigen(s) of MWF mycobacteria for environmental exposure assessment (fluid monitoring). Relative immunogenicity of the isolated different genotypes of MI (6) and MC (4) will be compared based on HP induction potential and cell-mediated immune response using our optimized mouse model and the putative protein antigens will be identified by differential immunoproteomic profiling. The recombinantly expressed antigens will be evaluated for their potential for immunodiagnosis using the mouse model and human subjects, particularly in terms of differentiation of the asymptomatic (exposed) versus symptomatic (HP patients) and for environmental exposure assessment. The resulting information will help NORA's objectives by providing a set of tools for mycobacterial exposure assessment and HP immunodiagnosis; these outcomes will facilitate future epidemiological studies and development of prevention (vaccination) and intervention strategies for MWF exposures in long-term.

Public health relevance
Project narrative Non-tuberculous mycobacteria (NTM) colonizing modern metalworking fluids (MWFs) have been associated with occupational respiratory illnesses. Recent studies by NIOSH and other groups have linked MWF mycobacteria with occupational hypersensitivity pneumonitis (HP) in exposed machine workers. HP is an immune-mediated lung disease caused by inhalation of microbial antigens. Hence, characterization of specific antigens in MWF mycobacteria and evaluation of their potential for HP immunodiagnosis and exposure assessment will facilitate development of pre-emptive measures and intervention strategies in MWF-associated occupational environments. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS AND HYPOTHESIS Overall goal of this study is to characterize key antigens of MWF-colonizing mycobacteria relevant to hypersensitivity pneumonitis (HP) and understanding their potential for immunodiagnosis of HP in the exposed machinists and in personal and environmental exposure assessment. Occupational HP due to MWF exposures has been listed as one of the top ten occupational pulmonary diseases (65). NIOSH and several other groups (45, 36, 47, 63, 75, 73, 74, 71, 78, 34, 21, 69; also see Background section) have provided increasingly convincing evidence that nontuberculous mycobacteria (NTM) species occurring in the in-use metalworking fluids (MWFs), Mycobacterium immunogenum and M. chelonae, are the 'agents of departure' among likely causal antigens of the immune-mediated respiratory disease hypersensitivity pneumonitis in machine workers exposed to contaminated metalworking fluids ('in-use' or 'used' MWF). Our preceding funding cycles have led to isolation of these two species of MWF mycobacteria and their multiple genotypes/strains (6 independent genotypes of Mycobacterium immunogenum and 4 of M. chelonae) based on the development and use of a series of DNA-based molecular methods for species-specific detection of mycobacteria in these fluids and for their characterization in terms of biocide resistance and antigenic potential. While the effective MWF monitoring for an early detection and characterization of MWF mycobacteria helps take pre- emptive measures and develop appropriate fluid management practices, equally important is the need for a specific personal exposure assessment to these mycobacteria in the exposed workers and immunodiagnosis in patients (using appropriate causative strain-specific antigen(s)) in order to reach a definitive exposure assessment/diagnosis and intervention strategies in HP environments. In this context, it is worth considering that the extent of mycobacterial colonization reportedly varies from plant to plant and that not all MWF lots with mycobacteria have shown associated HP cases; likewise MWF lots without detectable live mycobacteria have shown HP. We hypothesize that the underlying basis for these observed variations could be the critical antigenic diversity in MWF colonizing mycobacteria or the remaining cell-free causative antigen load (even after biocidal inactivation and/or lysis of mycobacteria). This emphasizes the need for characterization of the specific causal antigens, their prevalence in fluids, and their potential role in immunodiagnosis and pathogenesis of HP and exposure assessment. Despite the recognized role of microbial antigens in HP development, such studies on specific causal antigens in metalworking fluids have not even been attempted so far. Only two environmental mycobacteria (EM) species of the M. chelonae complex (namely, Mycobacterium immunogenum and M. chelonae) have been known to dominantly colonize MWF due to their unique inherent ability (unlike other mycobacteria species) to colonize these harsh fluid environments; of these, M. immunogenum has been frequently associated with HP-linked fluids and lately shown to induce HP-like symptoms in laboratory animals by us and others. Considering that HP is an immune-mediated disorder and that MWF mycobacteria species can induce such immune pathologies, there is a need to understand the critical antigenic strains of these two MWF- colonizing HP-linked mycobacteria species and the specific causative antigens in there that are associated with HP. Our initial studies have led to in vitro identification of antigenic proteins in M. immunogenum and M. chelonae using immunoproteomic approach. However, it is not yet known which of these antigens are critical in HP development and whether these antigens could serve as a target for immunodiagnosis in exposed workers versus HP patients and in more informative fluid monitoring. Due to the difficulties involved in accessing the relevant MWF mycobacteria-linked HP patients and obtaining HP patient samples (blood/sera) along with the corresponding contaminated metalworking fluid (or the mycobacterial isolates therein), it is not feasible to carry out a controlled study based solely on human cases. Hence, there is a need to use a mouse model of HP that has lately been optimized in our hands (see Preliminary studies). In view of the foregoing account, our overall goal is to identify and characterize critical antigens of MWF mycobacteria relevant in HP development and investigate them for developing a panel of antigens and methods for both personal exposure assessment (immunodiagnosis) and environmental exposure assessment (fluid monitoring independent of whole bacterial detection).In this context, we will test our hypothesis that antigen diversity in MWF- colonizing mycobacteria species (M. immunogenum and M. chelonae) prevalent in commercial MWF is responsible for differentially inducing the immune response underlying hypersensitivity pneumonitis symptoms, and that the key responsible specific antigens (cell-associated and secreted) could form the basis for more informative personal and environmental exposure assessment. Our specific aims are: Aim 1. Identify key antigens of MWF mycobacteria species M. immunogenum (MI) and M. chelonae (MC) based on their relative interaction with the host immune system in a mouse model of mycobacteria-induced hypersensitivity pneumonitis: A. Compare in vivo immunogenicity (HP-inducing potential and cell-mediated response) of the multiple strains (genotypes) of M. immunogenum and M. chelonae using our mouse model of mycobacteria-induced HP. B. Identify key antigens (cell-associated and secreted) in the potent mycobacterial strain of each species using differential immunoproteomic analysis. Aim 2. Recombinant Production of selected antigens of M. immunogenum and M. chelonae and generation of their specific antibodies: A. Identification and cloning of the mycobacterial genes encoding the selected antigens. B. Expression of the antigen genes for recombinant production of the selected antigens. C. Generation of monoclonal antibodies against the selected recombinant antigens. Aim 3. Investigate potential of the specific antigens of MWF mycobacteria for personal exposure assessment and immunodiagnosis of symptomatic (HP) versus asymptomatic (exposed) using the mouse model and human subjects. This will be based on both the humoral response (specific antibody response) and cell-mediated response from the asymptomatic vs. symptomatic and from early versus late stage of exposure. A. Identify organism-specific antigens of M. immunogenum and M. chelonae for immunodiagnosis. B. Evaluate the identified antigens for disease pathostage-specific immunodiagnostic potential in mice. C. Evaluate all potential diagnostic antigens on human patients and exposed subjects Aim 4. Identify and evaluate specific cell-free antigen(s) of MWF mycobacteria for environmental exposure assessment (fluid monitoring) using simulated and field samples. We will develop ELISA (for high antigen levels) or Immuno-PCR (for low antigen levels of detection) using simulated and field MWF. A. Identify cell-free antigens of the M. immunogenum and M. chelonae when grown in MWF. B. Evaluate potential of the selected species-specific antigen for MWF monitoring to assess mycobacterial antigen load by developing antigen-specific immunoassays and extend the evaluation to field MWF samples. We expect to identify a panel of key causal antigens across the genotypes of MWF mycobacteria with an immunodiagnostic potential to differentiate the symptomatic (HP patients) and nonsymptomatic (exposed) machinists and for fluid monitoring to assess mycobacterial antigen load. In future studies, these identified antigens are expected to serve as tools to understand etiological and immune mechanisms of HP and as potential molecular targets for developing vaccine and treatment strategies for occupational HP. This proposal addresses NORA priorities in the areas of exposure assessment and respiratory diseases and may lead to intervention research.